Role of MCT6 in mediating cisplatin-induced ototoxicity

ABSTRACT
Cisplatin is one of the most widely used anti-cancer drugs, however up to 70% of patients can suffer from severe
dose-limiting ototoxicity. Platinum-mediated hearing loss is detrimental to the early speech development of
children and can impede neurocognitive abilities, social integration, and financial status. Therefore, the long-
term goal associated with this proposal is to assess the role of membrane transporters in regulating damage
to cochlear cells following accumulation of cisplatin or its metabolites. The overall objective of this proposal
is to delineate the involvement of the monocarboxylate transporter, MCT6, in mediating cisplatin-induced hearing
loss. The central hypothesis is that MCT6 promotes uptake of an N-acetylcysteine S-conjugate metabolite of
cisplatin (NAC-1) resulting in severe damage to cochlear hair cells and loss of hearing. The rationale for this
project is that a predicted reduced functional genetic variant of MCT6 (rs4788863) was previously associated
with lower rates of cisplatin-induced ototoxicity. Evaluating the mechanism by which MCT6 contributes to
cisplatin-mediated hearing loss is necessary to address whether pharmacological inhibition of this transporter
would be protective of an adverse event that has no current curative or preventative measures. The central
hypothesis will be tested by pursuing two specific aims: 1) Investigate the ability of MCT6 to transport NAC-1;
and 2) Determine the protective effect of MCT6-deficiency on cisplatin-induced ototoxicity in vivo. Under the first
aim, in vitro models with high expression of MCT6 will be used to measure the ability of this transporter to
modulate uptake of NAC-1 as well as cisplatin. Additionally, the influence of the rs478863 genetic variant, or
pharmacological inhibition of MCT6, on platinum uptake or cytotoxicity will be assessed. Under the second aim,
a MCT6-deficient in vivo mouse model will be used to evaluate the severity of cisplatin-induced hearing loss in
the absence of the MCT6 transporter. Moreover, we will measure pharmacokinetic changes of cisplatin in MCT6-
deficient mice. This will provide mechanistic insight into the role of MCT6 in the handling of cisplatin or its
metabolites. The research proposed in this application is innovative because it represents a substantive
departure from the status quo by evaluating the role MCT6 as a regulator of cochlear damage via facilitating
accumulation of a toxic cisplatin metabolite. The proposed research is significant because it is expected to
identify MCT6 as a transporter that can be pharmacologically targeted to reduce the severity of, or prevent,
cisplatin-induced hearing loss associated with cancer therapy. Ultimately, such knowledge is predicted to reduce
the number of patients who would experience significant social and economic challenges, including in young
pediatric cancer survivors.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because it focuses on elucidating the role of a novel uptake transporter in mediating cellular accumulation of a cisplatin metabolite, which will enlighten how this metabolite promotes hearing loss. Once such knowledge is clarified, there is the potential significance to reduce cisplatin- induced ototoxicity by targeting transporters that regulate this process. Thus, the proposed research is relevant to part of the NIDCD mission that pertains to prevention of hearing loss and communication disorders.